Systematically mapping variant effects for cardiovascular genes

Cardiovascular diseases are leading global causes of death and disability, presenting as interrelated
phenotypes of atherosclerotic vascular disease, heart failure, and arrhythmias. They arise from interactions
between environmental factors and common and rare genetic variants, including relatively common Mendelian
lipid disorders, cardiomyopathies, and arrhythmias that collectively occur in at least 1/100 individuals. The
availability of genetic sequencing is altering clinical management, but a major barrier to the widespread
application of this practice is that the function of the vast majority of variants in key cardiovascular
disease genes is unknown. Variant effect maps that define function for nearly all missense variants in a target
sequence offer a way forward. This project brings together scientists at the forefront of variant effect mapping in
diverse cellular systems, illuminating underlying cardiovascular biology, establishing relationships between
variant function and human phenotypes, and working with others in multi-institutional collaborations. Our
CardioVar team will generate a comprehensive atlas of variant effect maps for key cardiovascular
disease genes.
In Aim 1, we will develop, optimize, and validate a range of high-throughput cellular assays. We will use a
range of generalizable (e.g. surface abundance) and bespoke (e.g. electrophysiological, lipoprotein uptake)
assays to directly measure variant function in disease-relevant context. Assays will be assessed by their ability
to discriminate pathogenic from benign variants.
In Aim 2, we will use in situ targeted mutagenesis or insertion of variant constructs at a safe harbor site to
generate pools of cells capturing all single-nucleotide changes in target genes. We will then deploy existing
validated assays and those emerging from Aim 1 to generate and validate variant effect maps at scale. Functional
scores and uncertainty estimates will be derived and evaluated, both by performance on pathogenic and benign
variants and on correlation with discrete and quantitative phenotypes in clinical cohorts.
In Aim 3, we will derive biological and clinical insights from variant effect maps. Discordant cases, where
variant scores diverge from clinical annotation, will be further investigated in zebrafish, iPSC-cardiomyocytes,
and automated patch clamping systems. Through a combination of hypothesis-driven analysis and machine
learning models, we will reveal relationships among variant effects, protein structure, protein function, and human
phenotypes. To optimize use of the atlas, we will provide a portal serving as a variant-centric decision support
system for evaluating functional evidence of pathogenicity. We will release variant effect map data pre-
publication via MaveDB (that we co-developed) and share all renewable variant assay reagents.
The CardioVar atlas of missense variant effects, covering key cardiovascular disease genes, will be an
essential and interpretable community resource for clinical and mechanistic studies of cardiovascular disease.

Public health relevance
Children aged 6 and 11 were resuscitated from cardiac arrest and found by our medical centers to have life- threatening heart rhythm abnormalities, and genetic testing found DNA variants altering a calcium-sensing protein called calmodulin (a known possible cause of these abnormalities); however, these variants were of uncertain significance. Because we had previously generated a ‘variant effect map’ of calmodulin by testing nearly all possible amino-acid-changing variants, functional evidence was immediately available to provide certainty to these patients’ diagnosis and enable genetic testing of calmodulin for other family members. Our CardioVar team proposes to generate variant effect maps for more than 25 key cardiovascular disease genes, providing systematic evidence of variant function to assist real-time clinical diagnosis and illuminate molecular mechanisms of cardiovascular disease.